The Community-based ART REtention and Suppression (CARES) App: an innovation to improve patient monitoring and evaluation data in community-based antiretroviral therapy programs in Lilongwe, Malawi

Differentiated service delivery (DSD) increases antiretroviral therapy (ART) access in sub-Saharan Africa (SSA)
by moving patients out of congested ART clinics to communities for care. Patient outcomes in DSD and traditional
clinic-based care appear similar at lower cost. Decreased donor funding, health system constraints, healthcare
worker (HCW) shortages, and COVID-related calls to reduce clinic visits, push DSD expansion. But, DSD settings
challenge routine patient monitoring and evaluation (M&E) required to ensure quality care, risking viral suppression
(VS), scarce resources, and epidemic control. Electronic medical record systems (EMRs) ensure effective patient
M&E in compliance with complex guidelines, improving patient outcomes and reducing workload. Yet, despite
decades of SSA EMRs investment, EMRs benefits do not extend to low resource/low infrastructure settings where
the majority of DSD occurs. How to optimize collection and use of high quality M&E for DSD patient care is a critical
implementation research priority. Lighthouse Trust (LT) operates two Ministry of Health (MoH) clinics in Lilongwe,
Malawi, with combined >35,000 ART patients. LT’s real-time, point-of-care (POC) EMRs collects complex M&E
data and provides decision-making support, ensuring adherence to integrated HIV/TB guidelines that optimize
patient and program outcomes. LT’s EMRs scaled to all large MoH ART clinics. LT implements a nurse-led
community-based ART program (NCAP), a DSD model to provide ART and rapid assessment to 2400 stable LT
patients in the community. LT’s EMRs requires consistent power and server access. Without EMRs, NCAP
providers lack embedded prompts and alerts, reducing integrated MoH ART guideline compliance. NCAP M&E is
incomplete and burdensome, leaving data gaps that lessen VS monitoring and care continuity. Poor M&E limits
NCAP expansion. Therefore, University of Washington’s International Training and Education Center for Health,
LT, and Medic seek to leverage a proven, open-source digital health framework to design, deploy, and assess an
offline-first, user-centered, battery-operated App, “Community-based ART REtention and Suppression” (CARES).
Apps are faster to design, simpler to deploy, cheaper to maintain, and operate without constant connectivity or
electricity. CARES brings a POC EMRs-like App to NCAP with real-time benefits for optimal, integrated patient
care. CARES captures complete patient M&E data and syncs to facility EMRs, improving data quality while
reducing workload. Guided by implementation science, we use a quasi-experimental, interrupted time-series
design to assess NCAP patient care, pre- and post-CARES. Mixed-methods evaluate CARES effect on NCAP
patient outcomes, data quality, workload, and cost. Aims: 1) Assess how CARES ensures high quality NCAP
patient outcomes using RE-AIM to gauge reach, effectiveness, adoption, implementation, and maintenance; and
2) Estimate CARES cost to improve M&E using a systems perspective. We hypothesize that CARES increases
NCAP on-time, annual VS testing from 65% to 80% at lower cost. COVID19 raises potential impact of this App to
strengthen integrated DSD care provision and to provide M&E evidence on DSD patient and program outcomes.

Public health relevance
In sub-Saharan Africa, differentiated service delivery (DSD) for antiretroviral therapy (ART) is scaling rapidly; however, poor patient monitoring and evaluation (M&E) in DSD settings compromises DSD patient care and program evaluation. We employ user-centered design to guide development, testing, and assessment of a battery-powered App for real-time, point-of-care patient M&E in public, community-based DSD settings in Malawi, optimizing outcomes and reducing workload. Implementation science methods and costing analysis rigorously assess how the App ensures DSD patient care that aligns with integrated care guidelines and provides DSD program evidence towards 95-95-95 milestones.